COBRE: LSU HSC: CELL & MOLECULAR ANALYSIS CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Cell &Molecular Core The Cell and Molecular Analysis Core provides facilities, service and training for COBRE investigators who use proteomics, cell culture, HPLC and electron paramagnetic resonance (EPR) technologies to achieve the specific aims outlined in their research proposals. This core also coordinates the junior and developing investigators'access to state-of-the-art flow cytometry facilities at LSUHSC-NO.